Acquisition of a Luminex Multiplex Platform

We propose to use a Luminex 200 System for multiplexed quantification of proteins and RNAs
from cell lysates. Our work focuses on post-transcriptional control of neural function with
emphasis on translational control of synaptic plasticity and learning and memory. We investigate
the neurodevelopmental and neurodegenerative disorders that arise when this translation goes
awry. We find that mis-regulated translation leads to changes in alternative splicing and RNA
degradation, which in turn contribute to neuropathology. More specifically, our research is
comprised of three distinct but complementary areas: (1) CPEB1 and cytoplasmic polyadenylation
control of translation; (2) FMRP regulation of translation with emphasis on ribosome stalling and
codon usage; (3) FMRP regulation of alternative splicing. CPEB1-regulated cytoplasmic
polyadenylation governs translation in post-synaptic compartments, which in turn modifies
synaptic strength, the underlying cellular basis of learning and memory. Molecular,
electrophysiological, and behavioral experiments from our laboratory have demonstrated that
CPEB1 regulates activity-dependent cytoplasmic polyadenylation-induced translation, which in
turn modifies synaptic strength, and cognition. CPEB1 nucleates several proteins that promote
poly(A) tail growth and removal and mediate translation initiation; they also regulate plasticity and
animal behavior. Another RNA binding protein important for brain function is FMRP, the product
of the Fragile X Syndrome gene FMR1. FMRP binds >1000 RNAs in the brain and regulates
translation, primarily by stalling ribosome translocation on specific mRNAs. One such mRNA
encodes the epigenetic factor SETD2, which catalyzes the chromatin mark H3K36me3. In FMRP-
deficient mouse brain, SETD2 levels are elevated and the H3K36me3 chromatin landscape,
which is principally located in gene bodies, is disrupted. H3K36me3 is linked to alternative pre-
mRNA splicing and there is widespread mis-regulation of splicing in FMRP knockout (KO) mice.
The main objectives our research going forward will address key unanswered questions regarding
RNA regulation of neural function, primarily using mouse models: (a) CPEB1-deficiency rescues
Fragile X pathophysiology in FMRP KO mice. Does this rescue involve ribosome stalling and/or
polyadenylation? (b) CPEB1 also regulates 3’UTR length. What is the mechanism by which this
occurs? (c) How does FMRP stall ribosomes on specific mRNAs? Does FMRP act as a molecular
roadblock to ribosome transit and/or does FMRP interact with the ribosome? (d) How does FMRP
regulate alternative splicing? Some of the mis-splicing events appear to involve H3K36me3, but
these are in the minority. Does FMRP regulate the translation of mRNAs encoding splicing factors,
and/or does FMRP, which is a shuttling protein, affect splicing directly? (e) How does FMRP
employ codon optimality to regulate translation and RNA stability? We will address these issues
by ribosome profiling, which we modified to distinguish between translocating and stalled
ribosomes, and direct nanopore RNA sequencing, which yields poly(A) tail size at near-nucleotide
resolution as well as RNA isoforms that arise by alternative splicing. We will deplete key regulatory
factors from the mouse brain and assess synaptic function and animal behavior.

Public health relevance
We propose to employ a Luminex 200 system for multiplexed quantification of proteins and RNAs, especially CPEB and FMRP, which both control RNA expression and regulate neural function. Because ablation of CPEB and FMRP lead to neurodevelopmental disorders including autism and Fragile X Syndrome, our work is directly related to human health.